Project-002

Kinases play a critical role in the development of heart failure (HF) and, therefore, represent a potential
therapeutic target. While the cardiac kinome is comprised of several hundred kinases, the vast majority of the
literature is focused on only a few kinases. Indeed, the function of numerous highly expressed cardiac kinases
is unexplored; these may include potential therapeutic targets for cardiovascular diseases. In order to identify
novel cardiac kinase(s) potentially involved in HF development, we employed an integrated transcriptome and
bioinformatics approach (Expression2Kinases (X2K)) with control and failing hearts. Indeed, in our screening
results, most of the identified kinases are well-known for their roles in cardiac biology, validating the applied
approach. Intriguingly, we also identified a novel kinase, Homeodomain-Interacting Protein Kinase 2 (HIPK2),
as potentially being involved in the regulation of cardiac remodeling and HF. Indeed, there is no literature
describing the function of HIPK2 in the heart. The overall goal of this proposal is to define the role of HIPK2 in
cardiac pathophysiology. As a first step towards this goal, we have generated mouse models including
fibroblast (FB)-specific HIPK2 KOs (periostinMCM and TCF21MCM) and cardiomyocyte (CM)-specific HIPK2 KOs
(αMHCCre and αMHCMCM). Three specific aims are designed to critically examine the role of HIPK2 in cardiac
biology. Aim 1: to define the role of HIPK2 in cardiac fibrosis and remodeling. We will test the hypothesis that
HIPK2 exerts a critical break on fibrotic remodeling by inhibiting profibrotic TGF-β1/SMAD-3 and p38
pathways. In Aim 2, we will test the hypothesis that CM-HIPK2 is essential in maintaining basal cardiac
homeostasis and required to protect against cardiac stress. We will utilize inducible CM-specific cre mice to
delete HIPK2 only in the fully mature CM, evaluate the mechanism(s) whereby HIPK2 may exert its
cardioprotective effect. Aim 3 will assess the therapeutic efficacy of AAV9 mediated HIPK2 gene therapy to
mitigate the pathologies induced by cardiac stress. Expression of HIPK2 is significantly reduced in failing
human hearts, we hypothesize that restoration of HIPK2 in cardiac cells will reduce and may reverse the
cardiac pathologies. AAV9-HIPK2 will be used to deliver the FB-specific (under periostin promoter and TCF21
promoter) and CM-specific (troponin-t promoter) gene expression. These studies will directly test the
translational potential of the findings from Aims 1 and 2. Thus, the proposed studies are of high significance,
not only by contributing translationally-relevant information but also by providing novel mechanistic insights into
cardiac pathophysiology.

Public health relevance
This proposal has direct public health relevance since it proposes novel strategies to prevent and treat heart failure which is a major public health problem with a worldwide prevalence of 38 million. By identifying the underlying mechanisms of heart failure, our studies should allow rational development of effective therapeutic approaches to prevent myocardial fibrotic remodeling and heart failure. Thus, the proposed research is relevant to the part of NIH’s mission that pertains to developing fundamental knowledge that will help to reduce the burdens of heart diseases worldwide.